Mapping Human Memory with Electrocorticography & Chronometric Stimulation

DESCRIPTION (provided by applicant): The goal of this project is to determine whether low frequency oscillations serve as a mechanism for coordinating cortical areas underlying human episodic memory. To address this issue, we will first employ innovative multilobular electrocortigraphic (ECOG) recordings in patients to determine the sets of interconnected brain areas underlying episodic memory, which previous research and our preliminary work strongly suggest to include the medial temporal lobes, prefrontal cortex, and parietal cortex. We will then perturb areas of high connectivity (hubs) in the same patients using chronometric stimulation, which involves simultaneous recording and stimulation from two different brain regions. Chronometric stimulation is advantageous because it involves stimulation that mimics the frequency and amplitude of on-going recorded activity in another brain region, potentially mitigating unwanted spread of stimulation to other brain areas and at the same time providing insight into how neural communication might actually occur. We will employ two different stimulation methods with this approach, either in phase or out of phase stimulation with the on-going recorded oscillations in connecting hubs. This will allow us to determine whether 1) areas with high degrees of connectivity (hubs) are necessary for episodic memory 2) whether in- phase, coherent oscillatory can enhance episodic memory retrieval 3) whether out-of- phase oscillations result in decrements in memory performance. Our approach here combines innovative tools, such as electrocorticography and chronometric stimulation in humans and analysis techniques involving graph theory. These in turn will allow us to advance our understanding of how and in what manner networks of brain regions interact as part of their role in episodic memory. This work is relevant to clinical research because it can provide insight into the extent to which other brain regions can compensate for lost function following stroke-related lesions to the medial temporal lobes, a known hub in episodic memory. It will also advance our understanding of potential ways to design and implement deep brain stimulators to treat cognitive impairments accompanying neural disease. For example, if the experiments outlined here are successful, they would imply that devices that time stimulation to be in-phase with distant recorded oscillatory activity could restore or even enhance impaired memory function in patients suffering from neural disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: A critical and unresolved issue regards how multiple brain regions interact as part of their roles in memory. Addressing this issue is important because the neural mechanisms necessary for episodic memory are not currently known. We propose to address this issue in humans by mapping the brain networks underlying episodic memory using graph theory, multilobular electrocorticographical recordings, and chronometric cortical stimulation.